Antigen discovery for transmission-blocking vaccines in Plasmodium vivax

Project Summary
For the immense undertaking by many malaria-endemic nations to eliminate malaria, interruption of malaria
transmission has been recognized as one of the greatest challenges, which requires integrated approaches.
Plasmodium vivax, the most geographically widespread human malaria, is more resilient to conventional
malaria control measures due to its intrinsic biology such as hypnozoite formation responsible for relapses and
earlier gametocyte development enabling transmission before manifestation of symptoms. Transmission-
blocking vaccines (TBVs) are a promising strategy especially suited for the task of elimination of vivax malaria.
However, the progress in TBV development has been very slow, whereas TBV research for P. vivax lags even
far behind that for Plasmodium falciparum. With only five parasite antigens as the top TBV candidates,
concerted efforts to identify new TBV antigens are urgently needed. In this application, we propose to use an
innovative antigen discovery pathway taking advantage of new protein expression and immunoscreening
technologies, and advancement in vaccine design and delivery platforms. We aim to 1) discover new sexual-
stage antigens by in silico prediction and immunoscreening, and evaluate their transmission reducing activities
in Plasmodium berghei; 2) evaluate a TBV combination strategy targeting both pre- and post-fertilization
antigens; and 3) assess the transmission reducing activities of new TBV candidates for P. vivax using
transgenic P. berghei and clinical P. vivax isolates. Results from these comprehensive studies will contribute to
a better understanding of sexual development in malaria parasites and identification of new sexual-stage
antigens for the TBV development pipeline.

Public health relevance
Project Narrative Development of transmission-blocking vaccines against the human malaria parasite Plasmodium vivax is urgently needed for malaria elimination. This project seeks to use a comprehensive antigen discovery pathway, including antigen identification through genome-wide immunological screening, validation in rodent malaria model, and further evaluation in P. vivax, to identify new transmission-blocking vaccine candidates for vivax malaria.